Graph Learning of Cell-cell Communications in Spatial Transcriptomics

PROJECT SUMMARY
Research Project: Studies have shown that extreme weather is associated with changes in disease severity
and activity. However, the molecular mechanisms influenced by atmospheric conditions that contribute to asthma
severity and activity are poorly understood, which prevents us in designing effective asthma treatments.
Furthermore, given climate change and increasing variability in daily atmospheric conditions, it is critical to
understand these gene-environment interactions on asthma for better control of asthma symptoms. Gene-
environment interactions have been previously reported as important determinants of risk for asthma, but the
exact nature of the relationships and the molecular signals associated with these interactions remain unclear.
Gene-environment interaction studies have mostly focused on exposure to pets, mold, smoking, occupational
exposure, air pollution, and other allergens. None of the studies have considered changes in atmospheric
conditions in the analysis, leaving a knowledge gap on the molecular mechanism of the interaction between
climate change and gene and its contribution to phenotypes of asthma severity and activity. To fill this knowledge
gap, we will explore the relationships between environmental factors collected from the nearest observatory and
genome-wide cell type-specific gene expression levels in patients with asthma as well as its contribution to
asthma severity and activity. To achieve this goal, we propose to 1) assess cell type-specific transcriptomic
changes in the circulation and airway of asthma patients associated with fluctuations in atmospheric conditions
and the contribution of their interaction to the phenotypes of asthma severity and activity, and 2) evaluate
perturbations in intercellular communication induced by fluctuations in atmospheric conditions.
Research design and methods: Tools developed in Aim 1 of the parent R01 will be applied to deconvolve the
bulk expression data based on single-cell RNA sequencing (scRNA-seq) data so cell type-specific transcriptomic
changes associated with fluctuations in atmospheric conditions can be identified. Tools developed in Aims 2 and
3 of the parent R01 grant will be applied to construct cell-cell communication networks in each patient and detect
perturbations in these networks associated with fluctuations of atmospheric conditions using the deconvolved
data. The contribution of identified atmospheric condition associated changes to the phenotypes of asthma
severity and activity will be evaluated. The bulk expression data, scRNA-seq data and clinical phenotypes of
asthma have been generated in Dr. Chupp’s lab and stored in the online YCAAD database that is constructed
and maintained by Dr. Rajeevan. The daily atmospheric condition data from the closest weather station
associated with each patient based on their zip codes will be downloaded and organized by Dr. Rajeevan.
Preprocessing of all the data and the analysis of the data using tools developed in the parent R01 grant will be
guided and supervised by Drs. Xiting Yan and Zuoheng Wang.

Public health relevance
PROJECT NARRATIVE To better understand the molecular mechanisms of the influences of climate changes on phenotypes of asthma severity and activity, our research effort will be devoted to identifying cell type-specific transcriptomic changes associated with atmospheric condition fluctuations, constructing cell-cell communication network, and detecting perturbations in the intercellular communications associated with fluctuations in atmospheric conditions in the airway of patients with asthma. The ultimate goal is to improve our understanding of interaction between cell type-specific gene expression and atmospheric conditions in the airway of patients with asthma and its contribution to phenotypes of asthma severity and activity for precise therapeutic development.